Structural Racism and Discrimination in the Expansion of Hospital Stroke Care Capacity: A Multi-Level Analysis on Access to Care, Treatment, and Outcomes

OTHER PROJECT INFORMATION – Project Summary/Abstract
Structural Racism and Discrimination in the Expansion of Hospital Stroke Care Capacity
Although advances in the treatment of stroke have significantly decreased morbidity and mortality for
stroke patients in the United States, there is a growing disparity in the provision of stroke services between
disadvantaged populations and others. No studies have examined the role of structural racism and
discrimination (SRD) in the expansion of stroke care capacity across communities and subsequent effects on
health disparity patients. The long-term goal of this project is to identify system-level pathways in the delivery
of acute stroke care that contribute to the growing disparities for NIH-designated health disparity populations
(defined as racial/ethnic minority, low-income, and rural patients). The overall objective is to determine the
mechanisms through which health disparity patients experience SRD in stroke care.
Using national data from 2009 to 2019, we propose three aims to test the following hypotheses: Aim 1,
That disadvantaged communities (defined as segregated areas with high shares of health disparity
populations) experience differential adoption of levels of stroke care, resulting in increased disparities in
potential access to care relative to other communities. Aim 2, That health disparity patients in segregated
communities experience increased disparities in actual access and treatment due to patient redistribution
across hospitals with different levels of stroke care and differential treatment within hospitals. Aim 3, That
individuals in disadvantaged communities and health disparity patients experience widening disparities in
health and functional outcomes.
In Aim 1, we will identify which types of disadvantaged communities, if any, were left behind in gaining
stroke care access, and whether racial or ethnic segregation and income inequality contribute to these
structural disparities in geographic access. These results will aid certification bodies to consider incorporating
community need in certification guidelines. In Aim 2, our results will illuminate patient redistribution patterns in
communities that gain access to stroke care and pinpoint patients who experience disparities in actual access
and treatment depending on their race, ethnicity, and income as well as the level of segregation in each of
those dimensions. Results will identify the types of communities where outreach might be most effective in
reducing disparities in stroke care. In Aim 3, our results will determine the extent of health disparities among
stroke patients a) between disadvantaged and non-disadvantaged communities after adoption of stroke care,
compared to communities with no change; and b) between health disparity and other patients within the same
community when those communities experience changes in stroke care, relative to those in communities with
no change in access to stroke care. These findings will identify specific communities where additional
interventions (e.g., mobile stroke units, enhancing telehealth access) could yield the greatest benefits.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative The proposed research seeks to determine how stroke center certifications have changed access, volume, care, and health outcomes over time across NIH disparity populations and communities. It is relevant to public health because it will provide local, state, and federal bodies with the empirical findings they need to create systems-level solutions to the delivery of stroke care that can both improve overall population health and narrow disparities among various segments of the population. The project directly addresses NIMHD’s mission because it seeks to “explain the causes, determinants, and influences of health and life course trajectories that result in health disparities,” by studying disparities at multiple levels: at individual-, facility- and community- levels and exploring consequences of system-level changes in the healthcare system for racial/ethnic, lower socioeconomic, and rural health disparity populations.